Histology Core

Summary
The Histology Core at UND was established to improve the infrastructure supporting our successful
implementation of the Phase 1 Center for Excellence in Host Pathogen Interactions COBRE at the University
of North Dakota School of Medicine and Health Sciences. The Core was developed to provide high quality
instrumentation, tissue preparation, staining, image analysis services, and training in a wide spectrum of
fundamental and advanced histological techniques to COBRE research investigators. The Core also provides
access and support to non-COBRE investigators within and outside the UND SMHS, as well as those from
institutions adjoining (USDA-Grand Forks Human Nutrition Research Center) and in neighboring cities (North
Dakota State University, North Dakota primarily undergraduate institutions and tribal colleges). The Core
remains essential for successful growth of the host pathogen interaction enterprise at UND and completing al
four of the projects proposed in this Phase 2 renewal application. The Core evolved from being a primarily
shared equipment facility with provided user training to now a complete drop off service facility for users across
the UND campus. Multiple tissue sectioning and staining services coupled with whole slide brightfield or
fluorescent imaging and image quantitation have made the Core invaluable to growth of the research
enterprise at UND. In Phase 2, the Core will continue to assist COBRE team members and the broader
UND/ND research community with experimental design specifically with regards to application-specific sample
preparation techniques, identifying appropriate analytical tools available, resolution restrictions, and quantitative
morphological techniques. The Core will also provide service, training, and instruction to COBRE and other
users in all aspects of instrument use, safety, tissue sample preparation, and aid with trouble shooting all
aspects of tissue preparation and analysis. Finally, the Core will implement a business plan that includes
strategies to continue expanding the user base and provide fee-for-service assistance in all aspects of histo-
and immunochemical detection methods and analyses, thus paving a way to long-term sustainability of the
Core.

Public health relevance
Narrative The Host-Pathogen Interaction (HPI) COBRE Histology Core Facility was established to provide high quality instrumentation, tissue preparation, staining, image analysis services, and training in a wide spectrum of fundamental and advanced histological techniques to COBRE research investigators. The Core also provides access and support to non-COBRE investigators within and outside the UND SMHS, as well as those from institutions adjoining (USDA-Grand Forks Human Nutrition Research Center) and in neighboring cities (North Dakota State University, North Dakota primarily undergraduate institutions and tribal colleges).